Identifying environmental pollutants detrimental to the cardiovascular system

Project Summary/Abstract
The current proposal represents a combined clinical and basic/molecular investigation which
seeks to examine mechanisms of vascular dysfunction associated with persistent organic pollutants
(POPs) and environmental toxicants that contribute to the pathogenesis of cardiovascular diseases.
Lipophilic pollutants that have contaminated our food chains and consumer products bio-accumulate in
human adipose tissues, some frequently termed “forever chemicals”, and negatively impact our health
including the cardiovascular system. Our application builds on our compelling preliminary data which, to
our knowledge for the first time, demonstrate that specific pollutants are causally linked to vascular
dysfunction, impaired angiogenesis, and inflammation, many at concentrations thought to be safe for
people. In this proposal, we will seek to characterize the pathogenic effects of diverse toxicants upon
the human vascular system by probing direct and indirect mechanisms owing to disruption of adipocyte
biology. We will employ several complementary approaches harnessing physiological studies of
vascular endothelial function and angiogenesis, cellular imaging, single molecule fluorescence in situ
hybridization (smFISH), RNA-Seq., cellular cross-talk experiments, and secretome proteomics analyses
to gain novel insights into molecular mechanisms linked to the pathogenesis of toxicant-mediated
disease. In Aim 1, we will characterize the effects of environmental chemicals on human vascular
function by examining endothelial vasodilator responses using videomicroscopy of live intact human
arterioles and perform angiogenic assays from human fat biopsies collected during elective surgical
procedures in 150 obese male and female subjects. In Aim 2, we will investigate the pathophysiological
contribution of toxicants to adipocyte dysfunction and their role in negatively skewing the adipose milieu
toward a pro-atherogenic secretome, and probe biological effects via adipocyte-endothelial crosstalk
studies. In Aim 3, we will turn to mouse models to test the ability of specific chemicals, starting with the
widely used pyrethroid pesticide permethrin, and also polyethylene nanoplastics to induce
atherosclerosis in an intact organism following a chronic, human relevant, low-dose exposure scenario
in susceptible ApoE-/- mice fed an American diet. Our approaches involve a diverse multidisciplinary
team and combine studies of physiology, molecular toxicology, cellular imaging, and in vivo chronic
exposure models to study perturbations in adipocytes and endothelial cells that synergistically promote
dysfunctional vascular phenotypes. The overall project tackles an unmet and urgent clinical need for
understanding how environmental pollutants, omnipresent in nearly every American household, play
causal roles in mediating vascular diseases. Our findings may impact public health policy and actions to
reduce exposure risk to many toxicants for which major health concerns are rapidly mounting.

Public health relevance
Project narrative Lipophilic environmental pollutants that have contaminated our food supplies and consumer products, some termed “forever chemicals”, can bio-accumulate in human adipose tissues and negatively impact our whole body health including the cardiovascular system. This proposal will investigate mechanisms by which environmental toxicants disrupt endothelial and adipocyte biology, and play causal roles in mediating vascular disease which represents a topic of high public health significance, affecting nearly every household and individual living in the United States.